Neural basis of flexible decisions in naturalistic environments

PROJECT SUMMARY
The brain does not simply passively process visual information about the objects in the world. It is charged
with placing this information about objects in the context of their environment relative to us in a way that helps
us interact with them. To forage for food in the wild, an animal recognizes distant fruits, weighs the effort to get
to each fruit against its perceived ripeness, makes and executes a route plan, and learns from the experience.
This is possible because our vision enables two remarkable abilities – filtering out irrelevant information like
inedible branches and leaves to focus on the fruit and creating flexible plans to reach the goal that can be
altered on the fly. To study the neural basis of these abilities, I will use new conceptual and technological
advances to study object vision in the context of cognition and naturalistic interactions like navigation and
foraging to formulate a unified theory of how vision enables flexible behavior.
Several computations in brain areas, like the prefrontal cortex, entorhinal cortex, etc., have been thought to
mediate flexible behavior in various cognitive contexts like attention, working memory, and navigation. In this
proposal, I will test the central hypothesis that signals in the dorsolateral prefrontal cortex (dlPFC) related to
those different forms of flexibility reflect computations that guide how object properties are read out of visual
area V4. To encourage the combination of several sources of visual information and interaction with objects in
the task, I have designed a virtual reality foraging platform to test the following hypotheses about how object
vision enables flexible behavior. In aim 1, I will test whether and how computations in dlPFC (previously
identified in the context of attention) mediate the foraging of objects that have a narrow range of learned
desirable properties by affecting the readout of relevant and irrelevant properties from V4. In aim 2, I will study
how object familiarity is encoded in a viewpoint-invariant fashion and how interactions between V4 and dlPFC
guide foraging behavior. In aim 3, I will explore how visual processing enables learned associations between
objects and sequential actions by comparing the changes in neural activity in V4 and dlPFC that lead to the
execution of sequential choices.
The results of these studies will have broad scientific implications for models of visual perception that
explain behavior and clinical implications for how object interaction, association, and action execution can be
impaired in stroke and Alzheimer’s disease patients while visual processing is spared. Skills gained in the
mentored portion – developing a visual foraging VR task and measuring and manipulating attention-like signals
in dlPFC – along with my experience in generating visual scenes to analyze neural coding, will set the stage for
future studies of the cognitive processes that shape visually guided experiences and actions in health and
disease.

Public health relevance
PROJECT NARRATIVE This project uses complementary psychophysical and electrophysiological approaches to evaluate the biological processes that underlie visually guided foraging behavior and will have two public health outcomes. First, it will inform the development of effective interventions for humans with diseases that impair navigation and object interaction while leaving visual processing intact. Second, it will suggest behavioral metrics and educational tools based on explicitly guiding visual attention for early detection of these disorders and to improve navigational decisions.